SCH: Overcoming the Intraoperative Data Desert: Biophotonics, Advanced Sensing, and Control for Automated Surgery

The overarching goal of this project is to conduct the foundational
research needed to demonstrate a closed-loop surgical control system that facilitates accurate, rapid, and
automated detection and laser resection of pathologic tissue with a focus on soft tissue sarcomas. Such a
system requires advancements in both detection and removal of STS, achieved through advances in
intraoperative imaging and control oflaser scalpels, respectively. This system will increase both the speed
and precision at which surgery is performed, thereby improving patient outcomes while reducing costs
and minimizing the devastating impacts of preventable morbidity. The imaging and image processing
technique developed in this work will overcome the intraoperative "data desert" of current practice for
both human surgeons and robotics systems.

Public health relevance
This research aims to improve detection of and automated removal of sarcoma tumors in mural models. By combining optical coherence tomography, fluorescent imaging, and computer-guided laser photoablation the intraoperative precision and extent of resection can be maximized over standard practice. Extent of resection studies with the experimental system will be demonstrated and characterized on phantom tissue models and in vivo mural sarcoma models.